AKAP Integration of Phosphorylation and Ubiquitin Signaling

PROJECT SUMMARY
Every heartbeat involves the coordination of local cAMP and Ca2+ signaling events that elicit the contraction of
cardiomyocytes. This recurrent process necessitates the reuptake of cytoplasmic Ca2+ through the
sarcoplasmic/endoplasmic reticulum Ca2+ ATPase (SERCA2). Pathophysiological changes in SERCA2 protein
expression following myocardial infarction have been linked to ubiquitin-mediated proteasomal degradation of
the channel. Thus, molecular mechanisms that remove ubiquitin from SERCA2 have the potential to be
cardioprotective. The Scott lab have discovered a macromolecular complex containing enzymes of the protein
phosphorylation and protein ubiquitination machinery. This new signaling unit may modulate SERCA2 levels at
the sarcoplasmic reticulum to facilitate healthy cardiomyocyte function. A more detailed investigation of these
molecular and cellular findings is mandated by evidence that cardiovascular diseases account for 1 in 3 deaths
in the US.
My preliminary findings show that the A-Kinase Anchoring protein AKAP18 sequesters the cAMP-dependent
protein kinase (PKA) and the ubiquitin-specific proteinase USP4 with SERCA2. Pilot studies in transfected cells
suggest that anchored PKA phosphorylates USP4 to stimulate its deubiquitinase activity. This led to a working
hypothesis that both enzymes, when associated with AKAP18, act cooperatively to protect against ubiquitin-
mediated removal of SERCA2 from the sarcoplasmic reticulum. This exciting new cardioprotective paradigm will
be tested by an experimental approach of two aims. Aim 1 will use state of the art biochemical and biophysical
approaches to investigate the molecular organization of the USP4-AKAP18-PKA complex. Mechanistic studies
in aim 2 will combine advanced imaging and in vivo genetic strategies to understand how these anchored
enzymes coordinately control vital aspects of cardiac physiology, such as calcium handling.
My research will be conducted at the University of Washington in the Department of Pharmacology. This
environment provides excellent training for academic-track postdoctoral researchers. Training benefits include
strong collaboration within and among departments, approachable principal investigators performing innovative
work, and frequent seminars from multiple departments featuring world experts in their respective fields.
Moreover, the training potential of these studies is high. I will learn cutting edge expansion microscopy imaging
techniques and will be introduced to measurement of calcium transients in live cardiomyocytes.

Public health relevance
PROJECT NARRATIVE Spatial control of cell signaling by anchoring proteins is a fundamental regulatory mechanism that permits the processing and integration of chemical messages at the same intracellular locus. We have discovered an anchoring protein that organizes the phosphorylation and deubiquitination machinery in the heart. This proposal will investigate how anchored modulation of these signaling enzymes protects against defective cardiac contractility, a major contributor to heart disease and stroke.